Dynamics of the Bacterial Ribosome and Proteome

Project Summary
This application describes a broadly based biophysical characterization of the process of ribosome assembly in
bacteria. Ribosomes are the essential machines in all cells that synthesize proteins, and in bacteria, ribosome
synthesis accounts for about one third of the energy expenditure for cell division. Ribosome biogenesis is
highly efficient, involving assembly of ~50 RNA and protein components, with the assistance of ~ 50 assembly
factors. This process will be will be investigated in vitro and in bactrerial cells using single particle electron
microscopy, mass spectrometry, cryo-electron tomography light microscopy. Electron microscopy of
intermediates that accumulate under perturbed conditions has revealed a distribution of structures that can be
ordered into a putative assembly pathway. A current focus is to understand the role of the assembly factors in
promoting efficient ribosome biogenesis. In addition, we are investigating the inhibition of ribosome assembly
both in vitro using nucleic acid hybridization, and in cells using CRISPR RNAs. Finally, we will characterize the
locus of ribosome assembly in cells using cryo-electron tomography to obtain structure and localization of
intermediates, and using MINFLUX nanoscopy to obtain nanometer scale information on the ultrastructure of
the heavily transcribed ribosomal operon. In the coming period, we hope to merge our molecular
understanding from in vitro studies with a physiological understanding of the central role of ribosome
biogenesis in bacteria.

Public health relevance
Contact PD/PI: Williamson, James R. PROJECT NARRATIVE This grant application describes broadly based biophysical characterization of bacterial ribosome assembly. We will investigate the role of assembly factors using cryo-electron microscopy, both in vitro and in cells, and the ultrastructure of the ribosome assembly locus in cells using a combination of MINFLUX super-resolution fluorescence microscopy and cryo- electron tomography. These combined data will develop a comprehensive mechanistic view of this central feature of bacterial cell physiology. Page 7 Project Narrative